Environmental ethoxylated surfactants and metabolic health dysregulation in zebrafish

Project Summary
The prevalence of metabolic disorders (e.g., obesity), continues to increase and imposes significant costs on
the US health care system. In the US, ~42% of adults (20+ years of age) are classified as obese Exposure to
environmental contaminants has been implicated as a causal factor, and some of these contaminants, termed
metabolic disrupting chemicals (MDCs), increase weight and lipid accumulation and/or perturb energy balance
and/or metabolic homeostasis, contributing to metabolic dysfunction including obesity. Polyethoxylated
surfactants (alkylphenols and alcohols) are emerging contaminants with ubiquitous human exposures and
robust effects on metabolic health. Used widely in hard surface cleaners, detergents, paints, pesticides, and
other products, polyethoxylated surfactants persist in the environment and contribute to chronic human
exposure. We have reported an obesogenic effect in zebrafish following developmental exposure to
nonylphenol polyethoxylates at environmentally relevant concentrations. In contrast, cetyl alcohol
polyethoxylates increased overall adiposity without any apparent impacts on body weights. Given the growing
use of these polyethoxylates in consumer products and the lack of comprehensive toxicity assessments on
them, it is crucial to determine how polyethoxylates differentially act to disrupt metabolic health. Our central
hypothesis is that these polyethoxylates preferentially promote an unhealthy visceral adipose expansion
through thyroid hormone receptor antagonism, in part through skewing the commitment of mesenchymal stem
cells to the adipose lineage at the expense of osteoblasts. Aim 1 will comprehensively assess the role of
thyroid receptor disruption in the observed effects through a combination of in vitro experiments (co-exposures,
siRNA knock-down, and chromatin immunoprecipitation with sequencing) and in vivo experiments (co-
exposures and genetic knock-down approaches) to rigorously assess the role of thyroid hormone in the
observed polyethoxylate-induced metabolic health effects. Aim 2 will directly interrogate the nature of
polyethoxylate-induced adiposity via comprehensive assessment of adipose tissue in developmentally exposed
zebrafish (histology and adipocyte morphometrics, immune cell infiltration, and metabolomics to measure
inflammatory mediators). Paired in vitro experiments will assess impacts on mesenchymal stem cell
commitment and differentiation through adipogenesis and osteogenesis assays and single cell transcriptomics
to evaluate how polyethoxylates disrupt cell fate and differentiation decisions. This research will move the field
forward by supporting a more integrated and physiologically relevant model of contaminant-induced metabolic
disease. Given the wide environmental prevalence of polyethoxylates, clear human exposure pathways, and
metabolic health impacts in a model with the potential for clear translation to human health, there is a critical
need to better characterize effects and their mechanisms. We expect results of our proposed studies will drive
additional research into these chemicals, most notably the AEOs that have received limited attention.

Public health relevance
Project Narrative The prevalence of metabolic disorders, such as obesity, continues to increase and impose significant costs on the US health care system; nearly 20% of children and adolescents and >40% of US adults are obese, and obesity-related health care costs account for nearly 10% of all US healthcare spending. Exposure to environmental contaminants has been implicated as a causal factor, and some of these contaminants, termed metabolic disrupting chemicals (MDCs), increase weight and lipid accumulation and/or perturb energy balance and/or metabolic homeostasis, contributing to metabolic dysfunction including obesity. This proposed award will support investigation into causal mechanisms underpinning metabolic health outcomes induced by exposure to ubiquitous indoor contaminants (polyethoxylated surfactants), supporting a comprehensive understanding of chemical-induced metabolic dysfunction.